Validation of biomarkers of infant and toddler carotenoid intake

PROJECT SUMMARY
Valid biomarkers of dietary fruit & vegetable intake can improve our understanding of the linkages between
infants’ and toddlers’ dietary intakes and health outcomes. Eating a variety of fruits & vegetables provides
energy, vitamins, minerals, and non-nutrient bioactives, and is associated with health benefits across the
lifespan. Introducing fruits & vegetables in infancy and toddlerhood supports their nutritional requirements and
lays the foundation for a long-term healthy dietary pattern. However, it is challenging for researchers and
organizations to easily and accurately monitor the fruit & vegetable intake of young children. A new application
of reflection spectroscopy may offer a non-invasive means by which infant and toddler carotenoid and fruit &
vegetable intake can be easily monitored. The technology measures the amount of carotenoids in the skin.
Carotenoids are fat-soluble pigments found in red, orange, yellow, and dark-green fruits & vegetables. Some
carotenoids convey pro-vitamin A activity, and are associated with visual and cognitive function and reduced
risks of adverse cardiovascular outcomes and some cancers. However, whether skin carotenoid measurement
is as reliable as the currently gold-standard measure of population fruit & vegetable intake, plasma carotenoid
concentrations, must be determined. Further, whether carotenoid intake in young children is associated with
visual function, a key bioactivity hypothesized for this population, is unknown. The purpose of this project is to
evaluate the validity of skin carotenoid measurement for estimation of infant and toddler fruit & vegetable and
carotenoid intake. Infants and toddlers will be longitudinally observed across solid food introduction and the
agreement between skin carotenoid measures with plasma carotenoids and reported carotenoid and fruit &
vegetable intake will be assessed. In a second study, the association between skin carotenoid measurement
with toddlers’ carotenoid concentrations, plasma carotenoids, and reported fruit & vegetable and carotenoid
intake will be observed at baseline, and then toddlers will be randomized to consume a controlled dietary
carotenoid intervention for 4 weeks to define the sensitivity of skin carotenoid measurement to detect changes
in dietary carotenoid intake. In a third study, we will define the associations of carotenoid intake with visual
function in toddlers and infants. This project will both define whether reflection spectroscopy is a valid measure
of infant and toddler fruit & vegetable intake and carotenoid intake, and will yield fundamental knowledge of the
determinants of and biological correlates of infant and toddler dietary carotenoid exposure.

Public health relevance
PROJECT NARRATIVE Rapid, easy, and valid biomarkers of carotenoid, fruit, and vegetable intake are needed to monitor the association between infants and toddlers’ dietary intakes and health outcomes. The purpose of this project is to determine if a rapid, non-invasive measure of skin carotenoids can provide a valid estimate of carotenoid and fruit and vegetable intake in diverse American infants and toddlers, and if children’s carotenoid intake is associated with their visual function. Simple and valid measures to estimate infant and toddler fruit, vegetable and carotenoid intake will promote our understanding of children’s nutrition and health, and will help organizations to monitor children’s dietary intakes as needed to promote healthier dietary patterns.